New Methods and Tools for Computational Drug Discovery

Project Summary
My goal is to develop effective and efﬁcient computational methods for drug discovery, apply these
methods to ﬁnd new and efﬁcacious drugs to treat diseases, and deploy these methods in easy-to-use open
source tools. My research group pioneered the development and integration of deep neural networks in
user-friendly molecular docking software for structure-based drug design to predict poses and potency of
small molecules binding to their molecular targets. We will build on our foundational work by using deep
learning to simultaneously solving the scoring and sampling problems, which will overcome scalability
limitations inherent in current approaches.
We propose to develop the ﬁrst deep generative models for structure-based drug design. Unlike tra-
ditional screening, generative modeling is not limited to a predeﬁned chemical space. In generative mod-
eling, a deep neural network learns an underlying distribution of molecular structures and properties
represented as a latent space. New structures can be extracted from this learned latent space to have
desirable properties. Ideally, a generative model will produce novel, near-optimal molecular structures
almost instantaneously. We hypothesize that training generative models using existing 3D protein and
ligand structures will allow us to create general models that can be productively applied to new, struc-
turally enabled targets due to the richness and universality of protein-ligand interactions. We will further
develop these methods to support the generation of optimized lead candidates, where the generative
process is updated to include results from experimental assays as the drug discovery process progresses.
We will continually apply our methods to identify small molecule modulators of molecular interac-
tions relevant to normal physiology and disease. For example, using our current tools, we identiﬁed the
ﬁrst inhibitors of the proﬁlin-actin interaction, an anti-angiogenesis target with relevance to cancer and
diabetic retinopathy, and we plan to further improve these compounds with the goal of identifying candi-
dates for clinical testing. We will apply our methods to address other under-explored molecular targets,
such as NFATc2, which is implicated in cancer and autoimmune diseases. These prospective applications
of our methods will provide unbiased and realistic evaluations that further inform their development.
Finally, all of our code and trained deep neural network models will be deployed either as new tools
for generative modeling or as enhancements to our widely used open source tools for computational drug
discovery: (1) PHARMIT, an interactive web application for structure-based drug discovery; (2) GNINA,
a C/C++ deep learning framework for molecular docking; and (3) the newly released LIBMOLGRID, a
Python library for accelerated molecular gridding that integrates with popular deep learning toolkits.
These tools and methods will make the drug discovery process more accessible and efﬁcient.

Public health relevance
Project Narrative The research supported by this award will develop new computational methods and tools for drug discovery so that novel therapeutics can be discovered more quickly and with less expense. The de- veloped methods will be evaluated prospectively in drug discovery projects of high relevance to human health. The resources developed will be readily accessible through open-access web sites and open-source software.